SimplePath II: A Cell-free Enzymatic Platform for Cannabinoid Biosynthesis

Project Summary
Cannabinoids (CNs) are bioactive natural products with many current and potential theoretical therapeutic uses
that are generally extracted from natural plant sources. While a few CNs are found at high abundance in plants
and therefore the most well studied, there are many other rare CNs that are also made in plants (e.g. the “varins”
cannabidivarin, CBDV, and tetrahydrocannabivarin, THCVA). Plant production of CNs, particularly rare CNs and
the acid forms of all CNs, is problematic because of crop variability, low abundance, purification challenges, and
environmental concerns. Consequently, there is considerable interest in producing both common and rare CNs
by metabolic engineering of microbes. Microbial production of CNs also faces daunting challenges, however,
and published titers so far are several orders of magnitude below cost competitive levels (8 mg/L).
Invizyne Technologies has developed an alternative cell-free method to produce common and rare CNs (and
other natural products) using enzymes. Our primary focus is production of the central CN precursors
cannabigerolic acid (CBGA) and cannabigerovarinic acid (CBGVA), because a variety of important cannabinoids
can be produced from CBGA/CBGVA in single enzymatic steps. Moreover, CBGA itself is bioactive and shows
promise for treatment of glaucoma, inflammatory bowel disease, and Huntington’s disease.
A key barrier to non-plant based production of CNs has been reliance on the native enzyme that makes
CBGA/CBGVA, Geranyl:Olivetolate Transferase (GOT), which is a membrane protein. In a major development,
we were able to design a highly active, specific, and water soluble GOT enzyme. With this GOT enzyme in hand,
we designed and implemented an enzyme system for the production of CBGA/CBGVA, that we call SimplePath,
that far exceeds cell-based production parameters by many orders of magnitude. Not only is SimplePath
tractable for commercial development, but it can already be used to make CNs at titers and scale large enough
to provide material for preclinical testing. Additionally, SimplePath can be used to make a variety of other CN
analogs beyond CBGA/CBGVA including new to nature molecules with potential to treat a number of indications.
Our goal in this Administrative Supplement to our Phase II award is to reduce costs and logistical burdens for
the SimplePath platform while promoting diversity and enhancing leadership opportunities for the Administrative
Candidate. As part of this effort, we will streamline logistics by setting benchmarks for the quality of enzymes
produced as well as implementing co-expression of enzymes. At the end of the Administrative Supplement, we
will perform techno-economic analysis on the effect of co-expression and enzyme quality on the costs of the
SimplePath system to guide pilot scale commercialization efforts and identify additional weak points that will
require focus. We also anticipate that our Administrative Supplement candidate will benefit significantly from
leadership and mentoring activities which will further support efforts at Invizyne to promote diversity.

Public health relevance
Project Narrative Our Administrative Supplement proposal to our Phase II SBIR award 3R44AT011482-02A1S1: SimplePath II: A Cell-free Enzymatic Platform for Cannabinoid Biosynthesis will expand our novel cell-free route to cannabinoids (CNs) to enable production of both common and rare CNs at high titer and high purity necessary for study and development of CNs as therapeutics. Our Administrative Supplement will allow our candidate to advance her career through mentorship and leadership opportunities while also allowing Invizyne to streamline and benchmark the SimplePath platform. Our innovative and inclusive approach will not only promote diversity and women in STEM but make rare CNs and other previously inaccessible natural products available to research and commercial markets. Work in this Administrative Supplement to our Phase II award is instrumental in advancing the career of our candidate and supporting both diversity and research efforts that support commercialization of difficult to source natural products at Invizyne.